NICHD - CONTRACEPTION SERVICES FOR NON-CLINICAL PHARMACEUTICAL DEVELOPMENT

The Contraception Research Branch is looking to utilize the services for non-clinical pharmaceutical development for contraceptives.